Synergistic effect of maternal insulin-resistance and cortisol in pregnancy on fetal programming of child mitochondrial function and obesity risk

PROJECT SUMMARY FILE NOT APPLICABLE FOR THIS REVISION PROPOSAL

Public health relevance
PROJECT NARRATIVE FILE NOT APPLICABLE FOR THIS REVISION PROPOSAL